Asian Resource Centers for Minority Aging Research (RCMAR)

Abstract: Overall RCMAR
We propose the Chicago Asian RCMAR to advance careers of investigators from underrepresented
populations through translational trauma and resilience research amongst one of the most understudied, yet
fastest growing populations in the U.S.: Asian American older adults. Such an important focus in
research, population and investigators will inform both practice and policy at community, regional and national
levels. Asians are the fastest growing yet most understudied US minority group at 21 million people and
growing 56% from 2000-2013. Yet, < 1% of NIH research funding in the last 10 years were focused on US
Asian populations, with only 3-5 total funded NIH grants/yr that focus on US Asian older adults. Moreover, this
population experiences the “Asian Paradox”: while on average, US Asians, are the highest-income earners
and the most highly-educated, more Asians, especially older adults, live below the poverty line, are less likely
to participate in biomedical research, and suffer disproportional health disparities compared to white
Americans. These health inequities are further complicated by the heterogeneity of these immigrant
populations, especially with respect to culture, religion, language, sexual identity, and trauma exposure, many
of which challenge our assumptions about the “model minority” stereotype. Such exposures and
heterogeneities lead to isolation and further removal from opportunities to participate in research, thus
restricting benefits conferred from population level research. However, despite this diversity, there are unifying
themes across Asian cultures with regard to shared experiences of immigration, trauma, strong family bonds,
cultural values and expectations, and the intergenerational nature of the aging process.
Building on two decades of rigorous aging research in minority populations and track records of
successful academic achievements, we have leveraged strong existing transdisciplinary partnerships across
multiple academic and community institutions to build a center designed to foster the next generation of
diverse researchers in a nurturing environment that is conducive to success and promotes highly relevant and
rigorous trauma, resilience and health outcomes research among Asian American older adults. We propose
the following scientific lines of inquiry: 1) Understand the cross-ethnic variations in the social, cultural, and
behavioral mechanisms of trauma and stress across Asian populations; 2) Explore the potential differential
health outcomes associated with trauma, immigration, and mechanisms of resilience in ameliorating adverse
consequences among Asian populations; and 3) Build institutional and community capacity that tests and
adapts and implements evidence based behavioral change strategies to prevent and treat trauma, promote
resilience, and mitigate the effect of stressful events in Asian aging populations. The overall aims of the
application reflect the synergistic work of Administrative (AC), Research Education (REC), Measurement and
Analysis (AnC) and Community Liaison & Recruitment (CLRC) Cores.

Public health relevance
Project Narrative: Overall RCMAR Despite the growth of US Asian populations, there are vast gaps in our knowledge regarding the social and cultural contributors to and consequences of trauma among Asian older adults, who are predominantly immigrants. In the Chicago Asian RCMAR, we will establish 4 complementary cores to achieve the mission of the Center, to improve Asian American older adult health through spawning research and a new cohort of diverse scientists that focus on this population.